4/14 APOL1 Long-term Kidney Transplantation Outcomes Network (APOLLO) Clinical Center

Abstract
Kidneys from deceased African American donors have reduced allograft survival compared to kidneys from
donors from European Americans. Likewise, kidneys from deceased donors with 2 apolipoprotein L1 gene
(APOL1) renal-risk variants, defined as APOL1 high-risk genotypes, have shorter allograft survival. Importantly,
many kidneys transplanted from deceased donors with 2 APOL1 risk variants do not fail rapidly. We postulate
that APOL1 interacts with other environmental or inherited factors to accelerate the failure of kidneys
transplanted from deceased donors. APOL1 renal-risk variants are almost exclusively in individuals of recent
African ancestry. Relative differences in the prevalence of blood types and human leukocyte antigens lead to
more kidneys from deceased African American donors being allocated to African Americans, potentially
exacerbating disparities in transplant outcomes. African American living kidney donors face a greater risk of
post-donation kidney failure compared to White living donors, but including APOL1 genotyping in the evaluation
and selection of African American donors remains controversial. The National Institutes of Health established
the “APOL1 Long-term Kidney Transplantation Outcomes” (APOLLO) Consortium in 2017 to prospectively
address several critical questions regarding the broad implementation of APOL1 genotyping in kidney
transplantation and to assess its role in the evaluation of living donors. APOLLO assesses factors determining
time to allograft failure (primary outcome), post-transplant kidney function and proteinuria (secondary
outcomes) in kidneys from donors with recent African ancestry. The APOLLO Consortium includes a Scientific
and Data Research Center (SDRC) and 13 Clinical Centers, including our Center with 8 kidney transplant
programs, encompassing high-volume and smaller programs with diverse practice patterns and geographic
representation. Through 9/29/22, APOLLO, in its initial phase, has prospectively collected DNA from 3604
deceased donors and is following outcomes for the 4890 recipients. APOLLO has collected DNA from 2436
recipients of whom Clinical Center 04 (CC04) has enrolled 17.1% (417). CC04 also recruited 7% (15) of the
APOLLO living donors and their recipients. In the proposed APOLLO Phase 2 study, we will prospectively
collect long-term follow-up data and measure urine albumin to creatinine ratio > 2 years after transplantation for
all APOLLO Phase 1 participants. For those at the University of Alabama at Birmingham, we will provide detailed
clinical data, collect biospecimens (blood and urine after 1st post-transplant year), and collect slides from all
allograft biopsies for APOLLO Digital Pathology Repository. Working with the SDRC, CC04 will return APOL1
genotype results to recipients and living donors at our aligned transplant programs. The results from this national
study have the potential to transform organ allocation and informed-consent processes for the transplantation of
kidneys from donors with recent African ancestry, improve kidney allograft survival, and elucidate the
mechanisms whereby APOL1 renal-risk variants produce kidney disease.

Public health relevance
Project Narrative Specific variants in the gene encoding apolipoprotein L1 (APOL1), which are generally restricted to persons with recent African ancestry, have been associated in retrospective analyses with an increased risk of end- stage native-kidney disease and shorter survival of kidney transplants. The proposed study will increase the number of living kidney donors and extend the follow-up of recipients of kidneys from deceased or living donors enrolled in the prospective APOLLO study that is examining the impact of APOL1 variants on kidney function while considering various environmental or comorbid conditions that can damage kidneys. The findings from this study have the potential to transform allocation of kidneys for transplantation, improve survival of transplanted kidneys, better inform potential kidney donors with recent African ancestry of the risks of donation, and provide a better understanding of the mechanisms whereby these genetic variants produce kidney disease.